Injuries of the Corneal Endothelium

In recent conflicts, explosions have been the most common cause of open- and closed-globe eye injury,
particularly from improvised explosive devices. These injuries cause damage to the corneal endothelium, a
non-proliferative monolayer of cells on the posterior layer of the cornea that regulates corneal clarity. The injury
may not initially affect vision because the corneal endothelium has a “reserve” capacity to withstand 80%
damage yet still retain function. However, the initial corneal endothelial cell (CEnC) loss can become significant
later in life, when additional CEnCs are lost during cataract (high energy ultrasound phacoemulsification) and
glaucoma surgery, conditions associated with both age and prior trauma with a high prevalence in the Veteran
population. Corneal opacification due to CEnC loss can only be corrected with corneal transplantation and is a
significant problem for both Veterans and civilians. This amplifies the need to identify sources of CEnC loss
and to minimize cell loss in these circumstances. There is minimal data on how trauma causes CEnC loss.
Preliminary data with post mortem human eyes show that CEnC injury from acoustic blast overpressure
exposure is not from immediate disruption of cell membranes, but from subsequent cellular and metabolic
injury. This provides a window of opportunity to intervene and rescue the injured cells. The objectives of this
study are to determine the signature of corneal endothelial damage from blast exposure in comparison to
iatrogenic CEnC loss and to determine if available pharmacologic therapeutics being studied for corneal
endothelial cell loss can be used to mitigate the damage to corneal endothelium suffered from blast injury. The
overall hypothesis tested in this study is that the mechanisms of corneal endothelial trauma from blast
exposure are similar to that from iatrogenic trauma from phacoemulsification and similar therapeutics will prove
to be beneficial for both conditions. This hypothesis is tested in three specific aims. All studies are performed in
fresh paired human post-mortem eyes where one eye serves as control and the other is exposed to the
experimental intervention. Aim 1 is to decipher the extent and mechanisms of corneal endothelial injury
following blast exposure. Eyes will be subject to blast injury from a shock tube device to generate acoustic
blast overpressure exposure. The corneal endothelium will be assessed immediately following trauma and at 3
days and 3 weeks following organ culture of the corneas to study the injury and healing response. Samples will
be analyzed for cell damage, death, proliferation, oxidative damage, and metabolism. Aim 2 is to compare the
mechanisms of corneal endothelial injury following blast exposure with corneal endothelial injury following
cataract and glaucoma surgical procedures. For these assays, eyes will be subject to phacoemulsification
damage or tube shunt insertion. Corneas will be analyzed with the same assays as specific aim 1 for
comparison to the effects from blast exposure. Aim 3 is to determine the effectiveness of pharmacologic
treatment for corneal endothelial injury following blast exposure and phacoemulsification injury with rho kinase
inhibitors (to enhance corneal endothelial wound healing), N-acetylcysteine (to reduce oxidative damage), and
ubiquinol (to support mitochondrial metabolism). In these studies, both eyes of a pair will be subject to trauma
by blast exposure or phacoemulsification. One eye will receive pharmacologic intervention and both eyes will
be compared for healing response focusing on the primary outcome of endothelial cell density. Successful
completion of the proposed studies will provide knowledge on the cellular and molecular signature of blast
overpressure injury on the human corneal endothelium, how it relates to common iatrogenic corneal
endothelial injuries, and the therapeutic response to drugs. These data will have significant implications for the
acute phase treatment of the corneal endothelium following blast or phacoemulsification injury. In addition to
benefiting military personnel who suffer blast trauma, these findings will benefit many Veterans undergoing
complex phacoemulsification cataract surgery by reducing the burden of blindness from CEnC loss.

Public health relevance
The cornea functions as a lens on the front of the eye and its clarity is maintained by the corneal endothelium, a delicate layer of cells on the back of the cornea. Because these cells do not divide, when they are lost from disease or trauma, there is loss of vision. The corneal endothelium can tolerate a fair amount of injury before the cornea opacifies. However, insults are cumulative. Injuries from explosions are the most common source of eye injury in our military personnel and blast injuries cause permanent damage to the corneal endothelium. History of eye trauma and age predispose Veterans to cataracts and glaucoma. Cataract and glaucoma surgery cause additional injury to the corneal endothelium which can destroy enough corneal endothelial cells to result in vision loss. Finding ways to prevent loss of corneal endothelial cells from blast-induced and surgery-induced trauma is an important endeavor to prevent corneal vision loss in our Veterans.